Molecular Degraders of Extracellular Proteins

Abstract
The majority of small molecule therapeutics function by inhibiting the target protein. Recent research has shown
that, in many cases, achieving the degradation of the target protein is more effective than merely
pharmacologically inhibiting it. This proposal focuses on the development of "Modular degradation of
extracellular proteins" (MoDEs) designed to enable the removal of extracellular proteins from circulation. Through
the proposed research program, we will (1) develop improved MoDEs with more favorable, druglike properties,
(2) establish a high-throughput assay and rigorous mathematical framework for evaluating MoDE candidates to
accelerate development cycles, and (3) demonstrate MoDE efficacy in an autoantibody-driven animal model of
autoimmune disease. This research will pave the way for the future clinical development of MoDEs to treat
antibody-driven autoimmune disorders and heart failure. To accomplish this, we have created and tested
bifunctional molecules with the capability to selectively deplete antibodies based on their epitope specificity, while
preserving the remainder of the immunoglobulin repertoire. This technology relies on bifunctional small
molecules, composed of a target-binding portion linked to a ligand for the asialoglycoprotein receptor (ASGPR)
on hepatocytes via a spacer. Upon the administration of these compounds, a ternary complex is formed among
the target protein, the bifunctional molecule, and the ASGPR on the surface of liver cells. This complex is
subsequently internalized into endosomes, leading to the trafficking of the target protein to lysosomes for
degradation. To develop improved MoDEs, we will use computer-assisted molecular modeling and medicinal
chemistry to adapt these novel ASGPR ligands into wholly small-molecule MoDEs. We expect that MoDEs
incorporating the small molecule ASGPR ligands discovered in our laboratory will exhibit improved affinity, oral
bioavailability, ease of large-scale production and profound improvements in PK/PD properties. To accelerate
the future development cycles of MoDEs, we will develop a bioluminescence-based high-throughput assay for
target protein endocytosis and lysosomal trafficking, as well as a mathematical model of the kinetics of the
intracellular process underpinning MoDE-dependent degradation. Finally, we will develop and test MoDEs that
incorporate antigen mimics to selectively eliminate pathogenic autoantibodies associated with heart failure while
preserving the healthy antibody repertoire.

Public health relevance
Project Title Molecular Degraders of Extracellular Proteins Narrative The proposed studies focus on the development of an innovative strategy for targeted degradation of pathogenic extracellular proteins including autoantibodies. These compounds will selectively deplete target proteins while leaving healthy proteins and antibodies intact. The proposed research is significant in that it constitutes a novel therapeutic paradigm for the treatment of autoimmunity and other diseases, overcoming many of the drawbacks of conventional therapies.